COBRE: LSUHSC: IMAGING AND HISTOLOGY CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Imaging and Histology Core The Imaging and Histology Core provides space, facilities, supervision and training for COBRE investigators who use microscopy of live-cells and histological specimens (fixed and frozen) stained with various stains and immunohistochemical antibodies to answer specific aims outlined in their research projects.